Discovery, biosynthesis and bioactivity of phosphonic acid natural products

Project Summary
Phosphonic acids, defined by the presence of stable carbon-phosphorus (C-P) bonds, are an underexploited
group of compounds with great biomedical promise, which stems from (1) a proven track record in clinical and
commercial applications, (2) an immense diversity of cellular targets and modes of action (3) availability of a
suite of research tools that allow facile discovery and characterization, (4) a proven reservoir of novel, unchar-
acterized members of the class, and (5) unusual biosynthetic pathways whose characterization has enhanced
and expanded our knowledge of fundamental biochemistry. This research project takes advantage of these fea-
tures, focusing on phosphonate natural products with useful bioactivities and interesting chemical features, as
well as the discovery of novel phosphonates. The long-term goals of the project include elucidation of the genes,
biosynthetic pathways, resistance mechanisms and bioactivities of selected phosphonates, as well as charac-
terization of novel enzymatic activities involved in their synthesis. The specific aims for the proposed funding
period are: (1) characterization of the biosynthesis and bioactivity of phosphonothrixin and related molecules,
(2) characterization of the biosynthesis and bioactivity of phosphonates produced by host-associated enterobac-
teria, and (3) development of improved genome-mining tools for phosphonate discovery.
Relevance
This research has the potential to discover phosphonate natural products with useful bioactivities and interesting
chemical features. Moreover, characterization of the genes, enzymes and biosynthetic pathways needed for
production of these compounds is likely to reveal novel biochemistry that significantly expands our understanding
of the chemical transformations catalyzed by microbes, while paving the way for creation of strains that overpro-
duce useful molecules and their derivatives.

Public health relevance
The goal of this project is to enhance our understanding of the chemical diversity, biochemistry, biosynthesis and bioactivity of phosphonic and phosphinic acid natural products, an underexploited group of compounds with biomedical promise. The proposed studies are expected to discover novel natural products with medically rele- vant properties, lend insight into the unique biochemistry and bioactivity of this molecular group, and create research tools that allow efficient discovery and development of similar compounds.